Representational dynamics for flexible learning in complex environments

Humans display tremendous flexibility in their everyday behavior, adjusting it rapidly when appropriate (i.e.
adopting mask wearing after onset of Covid-19), but not when inappropriate (i.e. continuing to drive after
involvement in an unavoidable car accident). Recent work has highlighted the role that transient fluctuations in
arousal, thought to be mediated by activation of the locus coeruleus norepinephrine (LC/NE) system, play in
behavioral adjustments. Increasing NE pharmacologically promotes behavioral updating in rodents and
peripheral measures of arousal, such as pupil diameter and P300 orienting response, provide a window into
the dynamics that underlie these behavioral adjustments in humans. A mechanistic understanding of these
processes could provide a valuable therapeutic target for a wide range of psychiatric disorders in which
behavioral flexibility is impaired. However, current theory falls short, in part because it fails to account for the
contextual nature of arousal: that heightened arousal reflects more behavioral adjustment in some settings or
individuals, but less in others. We believe that previous computational accounts of NE have likely failed to
explain heterogenous effects on behavior because they have ignored the neural representations on which NE
acts. Recent advances in computational neuroscience have highlighted the importance of neural
representations for efficient learning in complex environments, and provided tools to measure them. Building
on this work, we developed a computational model in which NE drives transitions in neural representation that
lead to behavioral adjustment when new representations persist in time (i.e. after Covid), but reduce behavioral
adjustment when they do not (after a freak accident). We propose that representational dynamics evoked by
NE are not random, but instead are governed by assumptions about environmental structure, which differ
across settings and individuals, to produce heterogeneous effects of arousal on behavior. This idea could
facilitate personalized predictions for how NE manipulations would alter behavior, potentially enabling better
treatment of attention deficit and anxiety disorders. Achieving this goal would first require basic research
experiments to better characterize the computational basis through which people recognize and respond to
changes in context. In this diversity supplement we will examine the computational basis for recognizing and
responding to changes in environmental features, specifically focusing on how such processes scale up in
higher dimensional feature spaces. The project will provide training in neural network modeling, Bayesian
modeling, experimental design, and behavioral analysis to a promising graduate student from an
underrepresented background who could leverage this training to propel him toward an independent research
position. We will develop models and test their predictions, as well as their relevance to various mental health
constructs, in a large-scale online validation study.

Public health relevance
Humans can show tremendous flexibility in every day life, rapidly recognizing and responding to contextual cues with appropriate behavioral changes, even in unfamiliar situations where the appropriate behaviors could not have been learned through direct experience. Here we examine the computational basis of this flexibility, with a particular focus on recognition of context changes can scale up to deal with high dimensional data. This work will provide an understanding of how the brain generates flexible behavior and serve as a foothold for future work seeking to understand what goes wrong in conditions characterized by failure to cope with uncertain and changing environments.